Learning, Memory, and Plasticity (LaMP) Training Program

Project Summary/Abstract.
This is the first renewal application for our advanced predoctoral Training Program in Learning, Memory, and
Plasticity (LaMP) at UC Davis. LaMP research at UC Davis is both broad and deep, spanning 6 schools and
colleges and all of the major levels of research—cognitive, systems, cellular/molecular, and disease. The 48
Trainers selected from this community are highly collaborative and value interdisciplinary approaches to their
research. Our innovative Program trains the next generation of neuroscientists to bridge the gaps between the
major levels of LaMP research—cognitive, systems, cellular/molecular—in order to promote our understanding
of LaMP disorders and reduce their tremendous burden on families, society, and public health. This renewal
application for our 4-year-old program proposes to continue to support 6 advanced predoctoral Trainees per
year, a size essential for creating a group that crosses traditional disciplinary boundaries, spans levels of
analysis, and addresses both basic and translational research. Trainees from 8 participating graduate groups
will be eligible to apply to the LaMP Training Program in Years 2 and 3 of their graduate training. The 1-year
Training Program has 6 components. (1) Trainees will conduct research in at least one of the LaMP faculty
labs and will be co-mentored by another trainer from a distinct area of LaMP research. (2a) Trainees will be
exposed to the essential and emerging concepts in each of the fields of LaMP through a 2-quarter core course
consisting of interactive lectures as well as lab-based immersion to give trainees the tools to understand the
pros and cons of both the concepts and methods used at each level of analysis. Methods to enhance
reproducibility will be addressed in every session. (2b) Trainees will also be exposed to LaMP disorders
through a course consisting of didactic and interview/video sessions that span clinical, cognitive, systems and
molecular aspects of each disease. (3) Trainees will receive targeted career development training through a
weekly meeting with the Program Directors—emphasizing critical and cross-disciplinary thinking, presentation
skills, formal discussion of research-related careers outside of academia, and pressing issues in the field such
as data analysis, ethics, and reproducibility. (4) Trainees will receive extensive training in grant writing prior to
submission of their NRSA or equivalent. (5) Trainees and Trainers will participate in a monthly meeting to bring
the community together around networking opportunities within the NeuroCareer Pathways program as well as
invited experts in the field. (6) Trainees will participate in an annual program retreat and attend an invited
LaMP speaker series. Our Program also emphasizes participation in outreach and diversity, equity, and
inclusion programs and workshops. Through these elements, this advanced Training Program will produce a
new, highly diverse generation of scientists who truly think across levels and scales and who have the skills,
drive, and motivation to work collaboratively to tackle the most important issues in learning, memory, and
plasticity in order to improve human health.

Public health relevance
Project Narrative. The proposed UC Davis "Training Program in Learning, Memory, and Plasticity (LaMP)" will allow us to continue to provide training across disciplines to bridge the gaps between the major levels of LaMP research— cognitive, systems, cellular/molecular—in order to promote our understanding of LaMP disorders and reduce their tremendous burden on families, society, and public health. Using this focused, innovative Training Program, we are producing a new generation of diverse scientists who truly think across levels and scales and who have the skills, drive, and motivation to work collaboratively to tackle the most important issues in LaMP in order to improve human health.